TR&D2: Nanoimmunomaterials for Immune Engineering

TR&D2 Abstract / Narrative - Nanoimmunomaterials for Immune Engineering
TR&D2 advances nanoimmunomaterials (NIMs) through the design and synthesis of new biomaterials and
nanomaterials created for immunomodulation. Polymers and polymeric particle-based systems are constructed
with independent control of the particle core physical properties and the chemical surface to enable desired
biomimetic biological properties. NIMs are constructed for intracellular delivery of nucleic acids, extracellular
presentation of biological molecules from surfaces, and for the combination of both mechanisms. These NIMs
are utilized for both immunostimulatory and immunosuppressive applications. Additionally, NIMs will be shared
with CP and SP projects, other TR&Ds, and for collaboration and use by varied researchers. NIMs will be
evaluated to improve the efficacy of techniques for both Adoptive Cell Transfer (ACT) and particle-based
acellular immunotherapeutics for wide ranging fields and applications to human health. TR&D2 supports and
aligns with the JH-TIE vision in its use of engineering principles (Chemical Engineering, Materials Science &
Engineering, and Biomedical Engineering) to design enabling immunoengineering technology and advanced
immunotherapy.

Public health relevance
TR&D 2 Narrative Not Applicable.